PHASE I TRIAL OF ETHYOL AND G-CSF WITH DOSE ESCALATION OF TAXOL IN PATIENTS

The purpose of this study is to determine whether Ethyol can protect against the myelosuppression and neuropathy associated with Taxol therapy. This is a phase I dose escalation study of Taxol with Ethyol and G-SF in patients with advanced cancer. Patients will undergo extensive neurologic testing before and after Taxol therapy.